Structural basis for ribosome function and inhibition in bacteria.

SUMMARY
Protein synthesis is an essential process in all living organisms catalyzed by the ribosome – one of the largest
and the most complex macromolecular machines created by nature. Our group uses structural, biochemical, and
microbiological techniques to gain insights into the molecular mechanisms of ribosome functioning in bacteria,
the modes of action of ribosome-targeting antibiotics, and mechanisms of drug resistance. Interaction of the
growing polypeptide chain with the nascent peptide exit tunnel (NPET) in the large ribosomal subunit during
protein synthesis plays a fundamental role in the regulation of gene expression as well as in co-translational
protein folding. Despite the extreme chemical diversity of its substrates and products, ribosome efficiently makes
all cellular proteins. However, some of the peptide sequences were evolutionarily selected to be problematic for
the ribosome resulting in translation arrest during their synthesis. The cell often uses this phenomenon of peptide
sequence-specific translation arrest, which can occur in a ligand-dependent manner turning the ribosome into a
small-molecule sensor, to control its metabolism. Currently, we lack a mechanistic understanding of how
interactions of the arrest peptides with NPET and small molecules or antibiotics result in the arrest of translation.
This knowledge gap could be addressed by structural studies capturing both arrested and non-arrested
Ribosome Nascent chain Complexes (RNCs) containing relevant peptides in the NPET. While many cryo-EM
structures of ribosomes carrying various stalling peptides became available in the past years, they all represent
arrested RNCs. Because the experimental approach used in these studies for the preparation of RNCs relies on
the ability of the ribosome to stall in the presence of a small molecule and a wild-type arrest peptide, using the
same methods for the preparation of respective non-arrested RNCs is impossible. Alternatively, the desired
arrested or non-arrested RNCs could be assembled from the individually purified components. However, this
strategy has remained challenging due to the lack of a reliable method for the large-scale preparation of peptidyl-
tRNAs. Recently, we have developed a chemoenzymatic approach based on native chemical ligation reaction
for facile semi-synthesis of peptidyl-tRNAs. Most importantly, by determining the first high-resolution structures
of non-arrested RNCs, we found that synthetic peptidyl-tRNAs can be efficiently complexed to the ribosome in
vitro and yet represent a functionally significant state of the ribosome’s catalytic site. Therefore, our group is best
suited to bridge the existing knowledge gap in our understanding of molecular mechanisms underlying antibiotic-
or sequence-dependent ribosome stalling by determining high-resolution structures of model RNCs under
arresting or non-arresting conditions. Altogether, the proposed project will uncover enigmatic mechanisms of
sequence-dependent nascent chain-mediated ribosome stalling, provide the structural basis for the context-
specific action of several chemically unrelated classes of ribosomal antibiotics, and reveal mechanisms of action
of ABCF ribosome protection proteins upon stalled ribosomes.

Public health relevance
NARRATIVE Protein biosynthesis, also known as translation, is a complex multi-step process essential to every cell and is catalyzed by the ribosome. Building on our solid expertise and previous experience in studying the structure and functions of the bacterial ribosome, the modes of action of ribosome-targeting antibiotics, and mechanisms of drug resistance, our future research will proceed in three main directions: (i) elucidating mechanisms of ribosome stalling; (ii) uncovering molecular mechanisms of context-specific action of ribosomal antibiotics; (iii) providing structural bases of antibiotic resistance. The newly gained knowledge will expand our understanding of fundamental aspects of protein synthesis and uncover the molecular mechanism of action of the most basic as well as the newest antibiotics that, in turn, will aid the future development of antibiotics that inhibit growth and possibly kill pathogenic bacteria more potently than the currently available drugs.